Pathogenic mechanisms of chronic lung sequelae following respiratory viral infection

SUMMARY
The COVID-19 pandemic has brought the world’s attention on respiratory viral infections. It is not a question of
if another respiratory viral pandemic will arise, but rather when. The diversity of viral pathogens presents a
tremendous challenge for designing virus targeted preventions and therapeutics. However, respiratory viruses
cause similar lung injury that drives morbidity and mortality. A focus on host mediated lung injury pathways in
this context is warranted, as there is potential for therapeutic interventions that would be effective across a range
of respiratory viral infections. The COVID-19 pandemic has drawn attention to a poorly characterized phenotype
of persistent lung inflammation that lasts well beyond clearance of live virus. Long-COVID and long-Flu are
clinical diagnoses that lack an understanding of the molecular underpinnings of disease. In this application, we
focus on understanding the mechanism by which respiratory viral infection causes lasting tissue damage
covering antigen persistence, presentation, and a positive feedback inflammatory cell network. We propose that
the persistent presence of viral antigen in pulmonary endothelial cells is a major driver for the prolonged
activation of CD8+ T cells, consequently leading to chronic pulmonary sequelae, through reinforced interaction
of CD8+ TRM cells and pro-inflammatory macrophages. This hypothesis will be tested in two Aims: 1) we will
investigate the contribution of persistent activation of CD8+ T cells by pulmonary endothelial cells to the
development of chronic pulmonary sequelae, and 2) we will interrogate the T cell and macrophage inflammatory
axis in persistent inflammation during recovery from respiratory viral infection. To examine these pathways, we
will employ the SARS-CoV-2 and influenza virus mouse models, and we will confirm findings using tissue from
human patient transbronchial biopsies. Discovery of causative host inflammatory pathways that are critical to
post-viral lung sequelae would provide pre-clinical evidence to support clinical trials. If pathogenic mechanisms
are indeed similar between multiple respiratory viruses, then host-directed therapeutics would potentially have a
tremendous impact. Currently, there are no specific therapies indicated for the treatment of post-viral lung
inflammation.

Public health relevance
NARRATIVE In recent years, the world has recognized that acute respiratory viral infections can be the cause of long term lung sequelae termed long-COVID or long-Flu. This can take the form of persistent inflammation, frustrated lung repair, and fibrosis. The goal of this study is to understand the molecular mechanisms by which lung inflammation persists in the context of preceding influenza virus or SARS-CoV-2 infection.